ADMINISTRATION CORE

This Administrative Core will ensure that effective communication and the flow of materials are maintained among the various projects and cores. The Core provide financial oversight and report scientific progress of the entire program to assure continued success. The Core director will work with program associates in ensuring that meetings between the PO1 investigators are scheduled regularly via face to face meeting as well as phone, emails, teleconferences, videoconferences, and WebEx presentations. These communications will ensure that the goals of the overall program projects are met and that all project and core budgets are administered properly. In addition, this core will act as a liaison between various performance sites to ensure effective utilization of institutional resources and as a catalyst to translate the discoveries made by the program project into early clinical testing in close collaborations with GI SOPRE of DFCI and other clinical departments. Finally, the Core will manage and ensure large datasets are properly deposited and useful reagents and animal models are distributed to research communities rapidly following the execution of material transfer agreement between institutions.

Public health relevance
The Administrative Core ensures effective communication between various projects and cores and work to provide financial management and ensure timely scientific progress towards the goals of the overall program projects.